Rescuing ⍺-synuclein toxicity through neuron-specific enhancement of autophagy

Project Summary
This proposal outlines a five-year career development program aimed at promoting the principal investigator to
research independence as a clinician scientist in basic and translational neuroscience, with specialization in cell
type-specific mechanisms that regulate neuronal autophagy and modify proteotoxicity in Parkinson disease (PD).
Applicant: The applicant has completed M.D. and Ph.D. degrees, residency training in neurology, and fellowship
training in PD and movement disorders. He has previous experience in neuroscience research using cell and
mouse models to study autophagy in spinobulbar muscular atrophy. His career development plan is designed to
focus his research on PD pathogenesis and advance his knowledge in bioinformatics, CRISPR gene editing and
high-throughput screening, and advanced imaging techniques. In so doing, the training plan outlined herein
builds upon his prior training to achieve research independence. He will benefit from continual mentor
engagement, regular meetings and ongoing collaborations. He will learn additional research techniques through
formal coursework, workshops, and national meetings. These training mechanisms will provide the applicant
with the scientific and conceptual skillset necessary for an independent career in neurodegenerative research.
Research Plan: PD is a progressive neurodegenerative disorder marked by motor and non-motor/multi-systemic
symptoms that lead to profound disability. There is no effective disease-modifying therapy currently available.
Neurodegeneration in PD relates to toxic aggregation of ⍺-synuclein, and mounting evidence shows that ⍺-
synuclein can be degraded through the conserved pathway of autophagy. However, current methods to modulate
autophagy fail to confer neuroprotective effects in patients. In recently published work, the applicant identified
MTMR5 (myotubularin-related phosphatase 5, encoded by the SBF1 transcript) as a potent neuronal autophagy
suppressor in neurons. MTMR5 knockdown enhances the sensitivity of neurons to induction of autophagy, and
accelerates the degradation of multiple autophagy substrates, including disease-associated and aggregate-
prone proteins. In line with this, this proposal will test the central hypothesis that reducing MTMR5 in neurons
augments autophagic clearance of ⍺-synuclein and reduces ⍺-synuclein-related neuronal death. The applicant
will use human induced pluripotent stem cells (iPSCs) to determine if manipulating SBF1/MTMR5 enhances ⍺-
synuclein turnover via autophagy (Aim 1) and modifies ⍺-synuclein proteotoxicity (Aim 2). He will also employ
unbiased, genome-wide CRISPR-based screens to uncover key factors regulating MTMR5 in neurons (Aim 3).
Collectively, these studies establish a novel research platform focusing on neuronal autophagy, myotubularin
biology, and therapy design in PD and related neurodegenerative disorders.

Public health relevance
Project Narrative Parkinson disease (PD) is an incurable and progressive neurodegenerative condition marked by the accumulation of ⍺-synuclein in affected neurons. To inform innovative therapeutic strategies with disease- modifying potential, this proposal takes advantage of a human induced pluripotent stem cell (iPSC) PD model system to investigate the autophagy suppressor, myotubularin-related phosphatase 5 (MTMR5). These studies promise to reveal discrete therapeutic targets for selectively augmenting autophagy in neurons and reducing neuronal death in PD, while simultaneously uncovering the unique biology of myotubularins and their contribution to autophagy flux in neurons.